GENERAL STRATEGY FOR SYNTHESIS OF ENANTIOPURE LACTONES

We made intermediates for the synthesis of eptazocine and aphenorphine. We used EI-MS and high resolution FAB-MS to verify the product[unreadable]s molecular formula.